University of New Mexico Leading Equity and Diversity in the Medical Scientist Training Program (UNM LEAD MSTP)

Project Summary/Abstract
New Mexico is an Institutional Development Award (IDeA)-eligible and “majority-minority” state, with a
population that is approximately 55% Hispanic, 10% American Indian/Alaska Native, and 28% White non-
Hispanic. The University of New Mexico (UNM) is the flagship university for New Mexico, and one of very few
Minority-Serving Institutions in the nation that is also classified as “Doctoral Extensive-very high research activity”
by the Carnegie Classification. We propose to transform our current MD/PhD program into a robust LEAD
MSTP through a combination of strongly supportive new leadership in the UNM Health Sciences Center
(HSC), increased institutional financial support, and the proposed MSTP support. Our MD/PhD program
has been highly successful in terms of inclusion of underrepresented trainees, degree completion, time to
completion, successful matching in high quality residencies and fellowships, and attainment of academic careers.
While program growth was limited over the last 20 years, the UNM HSC has committed to increasing the total
program size to approximately 20 trainees within five years and 40 trainees within ten years. UNM HSC has
recently undergone transformational leadership and institutional changes and has committed to furthering health
equity through education, research, workforce, and healthcare delivery systems.
The Program Mission is to provide outstanding training for the next generation of diverse clinician
scientists. Through the following objectives, the UNM LEAD MSTP will grow and enhance the translational
research ecosystem to improve satisfaction in training and persistence in clinician scientist careers. Objective 1:
Recruit students from underrepresented groups so that UNM LEAD MSTP trainees better reflect the
demographics of the region. Objective 2: Incorporate topics of developing innovation into the training programs.
Objective 3: Build on the existing MD/PhD program to provide rigorous clinical training with exceptional
predoctoral research training. Objective 4: Support and retain trainees throughout all stages of the program with
a goal of >90% of matriculants completing the program. Objective 5: Expand alumni engagement efforts to
expand the clinician scientist community at UNM and to support efficient transition to independent investigator
positions. Our specific goal is yearly engagement with >80% of graduates. Objective 6: Ensure robust
mechanisms for continuous program evaluation and improvement.
This Multiple PI/PD proposal will build on strong predoctoral training in the Biomedical Sciences Graduate
Program to incorporate training opportunities in Health Equity Sciences, Bioengineering, and Computational
Sciences. We have developed a plan for sustainable program growth that requests three training slots in year 1,
four training slots in years 2-3, and five training slots in years 4-5. We will provide a student-centered,
integrated training experience that builds on past successes to develop exceptional, diverse clinician
scientists who are prepared to address difficult issues in translational research and health equity.

Public health relevance
Project Narrative We propose to transform our current MD/PhD program into a robust LEAD MSTP through a combination of strongly supportive new leadership in the University of New Mexico Health Sciences Center, increased institutional financial support, and the proposed MSTP support. This Multiple PI/PD proposal will build on strong predoctoral training in the Biomedical Sciences Graduate Program to incorporate training opportunities in Health Equity Sciences, Bioengineering, and Computational Sciences. The University of New Mexico LEAD MSTP will provide a student-centered, integrated training experience that builds on past successes to develop exceptional, diverse clinician scientists who are prepared to address difficult issues in translational research and health equity.